Investigating the landscape and genetic architecture of germline mutagenesis

PROJECT SUMMARY
Variation in the efficacy of DNA proofreading and repair can alter germline and somatic mutation rates and
cause ripple effects on many important determinants of health, including the frequency of birth defects and the
likelihood of developing cancer. It is becoming feasible to measure mutation rate variation within and between
species, but we lack a solid frame of reference for its interpretation–for example, the clinical meaning of an ele-
vated mutation rate in a human family or the relevance of mutation rate to the survival prognosis of an endangered
species. The goal of this research program is to investigate why mutation rates vary within and between species
and to what extent this variation is shaped by selection to preserve longevity or population fitness. Since selection
can only act on variation that is genetically determined, it will first be crucial to disentangle the heritable compo-
nent of mutation rate variation from the effects of environmental mutagens or reproductive life history. We thus
propose several complementary strategies for identifying genetic variants that perturb mutation rates in germline
and somatic tissues. First, we will investigate the genetic architecture of somatic mutagenesis in the BXD mice,
a collection of recombinant progeny of the lab strains C57BL/6J and DBA2/J that we previously used to map
quantitative trait loci affecting germline mutagenesis. We will measure the rates and spectra of somatic mutations
occurring in aged BXD mouse tissues and test for associations between inherited alleles and the rate of mutation
accumulation over time. We will pay special attention to any somatic mutator effects of known germline mutator
alleles, including a Mutyh variant whose human homolog is linked to heritable colorectal cancer. Second, we will
scan for germline mutator allele activity in human whole genome sequence biobanks. We will cluster haplotypes
based on evidence that they were inherited identical-by-descent from the same common ancestor and identify
clusters whose mutation spectrum is inconsistent with the genomic background, indicating the likely presence of
a germline mutator allele that increases the relative rates of certain mutation types. After applying this method
to the UKBiobank, which includes many biometric and biomedical phenotype measurements, we will then test
whether mutator alleles tend to be associated with traits such as disease status, hormone levels and fertility.
Third, we will use a similar haplotype clustering method to identify mutations in whole-population pedigrees of
endangered Florida scrub jays and black rhinos and test for mutation spectrum shifts that appear consistent with
the presence of mutator alleles. We will then evaluate whether these data support a longstanding theoretical pre-
diction that selection against mutator alleles is inefficient in threatened populations with low effective population
sizes. Finally, we will measure the age dependence of de novo mutation rates and spectra in three strains of
the short-lived killifish Nothobranchius furzeri and test whether the rate of reproductive aging appears to have
accelerated in the populations that have evolved the shortest lifespans. Together, these studies will illuminate
how variation in DNA proofreading and repair efficacy may contribute to variation in health and longevity.

Public health relevance
PROJECT NARRATIVE All genetic diseases, cancers, and evolutionary innovations ultimately begin with genetic mutations. Despite the fundamental role that mutagenesis plays in human health, we know little about the genetic factors that deter- mine how many mutations we are likely to transmit to our offspring, and it is unclear whether these same genes also determine how we accumulate mutations in our bodies as we age. We propose strategies for identifying genes that cause mutation rates to vary within species and among tissues with the aim of illuminating how the evolution of lifespan might be functionally linked to the rates of birth defects in future generations.